Developing a bilingual speech neuroprosthesis

PROJECT SUMMARY/ABSTRACT
Anarthria, a loss of the ability to articulate speech, can be a severe symptom of neurological conditions,
including paralysis, stroke, and motor neuron disease. Invasive speech neuroprostheses that decode cortical
activity into intended speech have potential to restore naturalistic and rapid communication to patients with
anarthria and paralysis by bypassing diseased motor pathways. Speech decoding has expanded rapidly in recent
years. Multiple studies have demonstrated that English phrases may be decoded from cortical activity in
participants with anarthria. While these are critical milestones, an ideal speech neuroprosthesis would fully
restore communication to any person living with paralysis, regardless of their language background.
Currently, over half the world is bilingual with proficiency in at least two languages. Extensive qualitative
and quantitative research has demonstrated that bilingual speakers use each language in distinct social contexts
and report that their two languages contribute unique dimensions to their overall personality and worldview.
Despite this, prior speech decoding studies have exclusively focused on monolingual decoding. A key challenge
in developing a bilingual speech neuroprosthesis is decoding the intended language of the user in addition to
specific phrase content. Prior neuroscientific studies of bilingual speech have not provided a clear consensus on
the representation and localization of cortical activity patterns that are language-specific or shared across
languages. Thus, to develop a bilingual neuroprosthesis, we must first understand the basic cortical mechanisms
that underlie bilingual speech. Based on our preliminary data and prior literature, we hypothesize that lexical
access is language-specific and supported by higher-order speech regions (i.e., inferior frontal gyrus) whereas
vocal-tract articulation is shared and supported by the speech sensorimotor cortex (SMC). We hypothesize that
these representations will be sufficient to decode both intended language and specific phrase content in
participants with anarthria. SMC articulatory activity, specifically, may facilitate rapid generalizability of decoders
across languages.
To test these hypotheses, we propose studying bilingual speakers and bilingual participants with
anarthria, using high spatio-temporal resolution electrocorticography (ECoG). In aim 1, we will record cortical
activity while bilingual speakers produce a large set of unique English and Spanish phrases, allowing us to
assess whether shared or language-specific cortical activity underlies bilingual lexical access and articulation. In
aim 2, we will develop algorithms, in bilingual participants with anarthria, to decode cortical activity into intended
language and phrases. Finally, in aim 3, we will explore which cortical representations and regions allow content
decoders to rapidly generalize across languages, reducing training times for system users.

Public health relevance
PROJECT NARRATIVE Neurological injuries, such as stroke or motor neuron disease, can lead to loss of speech, significantly limiting communication abilities and negatively impacting quality of life; however, speech neuroprostheses offer hope in restoring communication by directly decoding cortical activity into intended speech. Despite over half of the world's population being bilingual and each language contributing unique dimensions to bilinguals' personality and worldview, previous decoding studies have predominantly focused on monolingual speech. In light of this, the proposed project will investigate the precise cortical activity patterns that underlie bilingual speech and use these findings to develop a bilingual speech neuroprosthesis capable of decoding cortical activity into language- specific phrases.